Family processes underlying adolescent substance use and conduct problems: disentangling correlation and causation

PROJECT SUMMARY/ABSTRACT
During adolescence, substance abuse and conduct problems are co-occurring and mutually reinforcing
problems with significant acute and long-term burden to adolescents, their families, and society. Family-based
treatments and prevention programs can reduce their incidence, but these interventions are limited in the size,
duration, and scope of effects and can be cumbersome to implement. One factor limiting the refinement of
these existing interventions is the difficulty of conducting rigorous science about the specific causal effects of
the family factors that are targeted as mechanisms of change. Factors such as parental monitoring, parental
warmth, and family conflict covary with each other as well as many other variables (e.g., genes, socioeconomic
status, living environment, parent psychopathology), so it is difficult to isolate their unique impacts on
adolescent outcomes from the larger causal network of risk factors. This proposal pursues a causally
grounded, mechanistic approach to disentangle the impacts of family processes and characterize how they
vary by the severity, chronicity, and developmental timing of exposure at the population level. We draw data
from the Adolescent Brain and Cognitive DevelopmentSM (ABCD) Study—a diverse, longitudinal, nationwide,
population-based cohort of 11,880 youth ages 9/10 years old followed prospectively until ages 19-20, with
simultaneous measurement of many intercorrelated aspects of development at biannual assessments
throughout. We will attempt to isolate the effects of parental monitoring, parental warmth, and family conflict
from other influences using three distinct, and complementary approaches: (A) a between-subjects approach
using marginal structural models; (B) a within-subjects approach using the fixed effects panel estimator; (C) a
twin/sibling discordancy approach using 336+ pairs of monozygotic twins, 430+ pairs of dizygotic twins, and
1,805 non-twin siblings. We pursue four specific aims. Aim 1: Determine the causal impacts of three family
processes—parental monitoring, parental warmth, and family conflict—on proximal adolescent substance
abuse and conduct problems between ages 11 to 18 years. Aim 2: Determine whether the effects of the family
processes vary by youth sex, racial/ethnic identification, or predisposition to substance abuse and conduct
problems. Aim 3: Determine whether the effects of three family processes vary by severity, chronicity, or
developmental timing of exposure. Altogether, this research will yield a more scientifically accurate
developmental psychopathology of adolescent substance abuse and delinquency and thereby inform the
design, refinement, and personalization of family-based interventions to reduce the incidence of these
problems at the population level.

Public health relevance
PROJECT NARRATIVE The proposed research will study the specific causal impact of three modifiable family processes—parental monitoring, parental warmth, and family conflict—on substance abuse and delinquency during adolescence in a diverse, population-based cohort. This knowledge will improve the accuracy of etiological models and guide the refinement and personalization of (preventive) interventions to reduce the burden of these problems on adolescents, their families, and society.